A Neurosensory Account of Posttraumatic Stress Disorder

ABSTRACT
Posttraumatic stress disorder (PTSD) is a common and highly disabling psychiatric disorder. Pathological
fear is at the core of PTSD, and accordingly, neural accounts of PTSD have emphasized dysfunctions of
the fear system (primarily, the amygdala-prefrontal-cortex fear circuit). Motivated by recent expansion of
the fear circuit into the sensory cortex and growing recognition of rich sensory anomalies in PTSD, we
have proposed a neurosensory account of PTSD, integrating basic sensory cortical pathophysiology with
amygdala-prefrontal-cortex dysfunctions into a tripartite Sensory-Prefrontal-cortex-Amygdala (SPA)
pathology of PTSD. Specifically, we propose that PTSD involves sensory cortical disinhibition that
exacerbates amygdala-prefrontal-cortex dysfunctions, which in turn impairs top-down regulation, resulting
in a vicious cycle of SPA pathology.
The current project seeks to elucidate three specific mechanisms in this account: (Aim 1) Intrinsic (tonic)
sensory cortical disinhibition that maintains SPA pathology in PTSD (by sustaining intrinsic amygdala-
prefrontal-cortex dysfunctions with excessive spontaneous sensory afferents); (Aim 2) Novelty-related
(phasic) sensory cortical disinhibition that drives SPA pathology in PTSD (by heightening sensory cortical
reactivity to novel cues, resulting in excessive sensory output that drives amygdala-prefrontal-cortex
dysfunctional response to novelty); and (Aim 3) Threat-related sensory cortical disinhibition that
exacerbates SPA pathology and threat biases in PTSD (by heightening sensory cortical reactivity to threat
stimuli and synergizing with biased sensory cortical encoding of threat, resulting in excessive, threat-laden
sensory output that exacerbates amygdala-prefrontal-cortex dysfunctional response to threat). This
project will leverage our fully-developed cutting-edge methodology of simultaneous EEG-fMRI combined
with non-invasive neuromodulation (specifically, transcranial alternating current stimulation/tACS to
enhance sensory cortical inhibition), thereby permitting integrative spatial and temporal assays and causal
inferences. This mechanistic investigation has the potential to break new theoretical ground by revealing a
tripartite SPA pathology of PTSD. Clinically, identification of sensory cortical disinhibition as a
fundamental mechanism that is malleable (via neuromodulation) would open a new line of mechanism-
based treatments for PTSD.

Public health relevance
PROJECT NARRATIVE PTSD is a highly debilitating mental illness that is difficult to treat. We have proposed a novel neurosensory account of PTSD emphasizing a tripartite sensory-prefrontal-cortex-amygdala (SPA) pathology. Taking a mechanistic, cognitive-affective neuroscience approach to elucidate this SPA pathology, this project will generate rich insights to significantly advance the conceptualization and treatment of PTSD and related disorders.